Breaking Spatiotemporal Barriers of MR Imaging Technologies to Study Human Brain Function and Neuroenergetics

PROJECT SUMMARY
Understanding how neural circuits operate and interconnect at mesoscopic (sub-­millimeter) scale, and how
neuroenergetic metabolism and neurotransmitters support brain function at resting and working state is
essential to brain research and BRAIN Initiative. Magnetic resonance (MR) imaging (MRI), including functional
MRI (fMRI) and in vivo MR spectroscopic imaging (MRSI), is the sole modality enabling to imaging neural
activity, functional connectivity and brain structure at cortical layer and column level, neuroenergetics and
neurotransmitters in human brain. However, it remains challenging to address fundamental neuroscience
questions requiring much higher sensitivity and spatiotemporal resolution currently unavailable. Increasing MR
field strength has been the prevailing paradigm to tackle the challenge, however, beside high cost, it poses a
safety concern from elevated specific absorption rate (SAR) of radiofrequency (RF) power in the brain tissue.
To address the technical challenges and limitations faced by the MR-­based imaging techniques, we have
pioneered an innovative and cost-­effective engineering solution by introducing the ultra-­high dielectric constant
(uHDC) former incorporated with RF coils for large improvements of sensitivity and spatiotemporal resolution for
fMRI and MRSI, and synergistically reducing SAR at ultrahigh field (UHF). With the NIH R24 funding support, we
have made progress with promising results for proof of concept. In this U01 proposal, we will further develop
and integrate three advanced technologies: i) fixed and/or tunable uHDC formers incorporated with advanced
RF coil technology for maximizing MR sensitivity and minimizing SAR;; ii) SPectroscopic Imaging by exploiting
spatiospectral CorrElation (SPICE) technique for significantly boosting signal-­to-­noise ratio (SNR) and
spatiotemporal resolution;; iii) UHF MR technology for further improving sensitivity and spectral resolution of
MRSI. The integration of these technologies will achieve cumulative and unprecedented improvements at UHF
and break current barriers of spatiotemporal resolution, ultimately enable i) ultrahigh-­resolution fMRI mapping
of neural activity, circuits and dynamics, and functional connectivity and networks at mesoscopic scale at 3 and
7 tesla(T);; and ii) very high resolution and whole-­brain multinuclear MRSI for functional mapping of
neuroenergetic and neurotransmitter changes in response to brain stimulation at ultrahigh fields (7T and 10.5T)
with an superior (£5mm isotropic) resolution comparable to conventional fMRI. The technology developments
will be carried out by a consortium among interdisciplinary researchers from University of Minnesota, Penn
State University and University of Illinois at Urbana-­Champaign. Success of this project will usher the next
generation of MR-­based multimodal neuroimaging technology offering superior spatiotemporal resolution fully
transformative for broad brain research, and generate comprehensive and high fidelity database of healthy
human brain that can be shared by scientific community.

Public health relevance
PROJECT NARRATIVE This project aims to develop novel neurotechnology and break the spatiotemporal resolution barriers of current state- of- the- art neuroimaging. The technology advancement will open new opportunities for cutting- edge neuroimaging research to address challenging neuroscience questions and understand human brain function in depth and broad perspectives, and it could potentially benefit clinical diagnosis with significantly improved precision for personalized medicine.